Myocardial remuscularization by cardiac patch delivery of epicardial FSTL1 and CCND2 overexpressing cardiomyocytes

Title:
Myocardial remuscularization by cardiac patch delivery of epicardial FSTL1 and CCND2
overexpressing cardiomyocytes
Project Summary
Despite undergoing intensive treatment regimens, patients with severe acute myocardial infarction (AMI) often
end up with end stage congestive heart failure (CHF). From the molecular and cellular perspective, heart failure
occurs due to the loss of the contractile unit of the left ventricle: cardiomyocytes (CMs). Therefore, promotion of
myocyte proliferation and understanding the regulators of myocyte cell cycle could have highly significant impact
on the management of heart failure. In this proposal, we seek to develop 3D bioengineered cardiac muscle
constructs that incorporate a functional vascular network and recapitulate some of the key microenvironmental
cues of native heart tissue. Our recent studies have identified main biomechanical and molecular cues that can
significantly enhance cell cycle re-entry of adult CMs. We demonstrated that epicardial application of a cardiac
patch, laden with follistatin like-1 (FSTL1) protein, protected the mouse and pig heart against AMI, left ventricle
dilatation, and heart failure. We recently reported that overexpression of a cell cycle gene, CCND2 (cyclin D2),
induces proliferation of transplanted human induced pluripotent stem cell (hiPSC) derived-CMs. This proposal
builds upon our recent technological achievements, enabling cast or bioprinting of major cardiac cells and
hydrogels at high spatial resolution (20 µm) to fabricate 3D perfusable vascular constructs. Our central
hypothesis is that 3D cardiac constructs, laden with FSTL1 and hiPSC-CCND2 CMs, can synergistically
remuscularize ischemic myocardium. We test this hypothesis in three integrated Specific Aims (SAs). In SA1,
we will utilize our cast/bioprinted 3D cardiac tissue models to identify the cellular and molecular mechanisms
underlying myocyte pro-proliferative effect of FSTL1 treatment in vitro. In SA2, we will assess the identified
signaling pathways, involved in FSTL1-CCND2 CM-patch effect, to promote remuscularization in mouse model
of MI (both acute and chronic). In SA3a, we will assess the pre-clinical potential of bioengineered pre-
vascularized muscle patch device in treating AMI in a pig model of ischemia-reperfusion. We will compare the
efficacy of open chest delivery versus a novel minimally invasive, catheter-based, pericardial delivery of FSTL1
and CCND2 CM laden muscle patch to the epicardium. SA3b, we will evaluate the effectiveness of the
engineered patch for preventing the LV dilatation without inducing arrhythmogenic complications. The panoramic
optical mapping and transmural electrical EP mapping whole heart will assess the electromechanical integration
between the muscle patch constructs and recipient myocardium. The findings from these EP studies will guide
the design of new generations of cell lines and patch constructs with improved EP characteristics, thereby
reducing the risk of graft-associated arrhythmia

Public health relevance
Project Narrative The project will establish a novel generation of personalized cardiac patch devices for remuscularization of heart with postinfarction LV remodeling, which is one of the most significant problem in public health. The central hypothesis is that the novel bioengineered and perfusable cardiac patch using novel hiPSC lines, can remuscularize the ischemic injured heart using minimally invasive technologies. The findings will have significant impact in diagnostic and treatment of heart failure, and improve the public health.